Falls Related Injuries and Hearing Loss: Understanding the role of hearing healthcare intervention

ABSTRACT
Falls and falls-related injuries result in substantial morbidity, mortality, and disability among older adults.
Recently, sensorineural hearing loss and hearing handicap have been identified as independent risk factors for
falls. There is an established dose-effect, in which increasing hearing loss severity and/or greater perceived
handicap from hearing loss increases the odds of falling. It is unclear if falls can be mitigated by treatment of
hearing loss with hearing aids or a cochlear implant. The long-term goal is to identify and understand the
mechanisms that mediate the association between falls and hearing loss in an effort to develop interventions
that will modify falls risk in this patient population. The current objective is to determine if amplification modifies
the odds of falls-related injury in older adults. To address the current objective, the following specific aims will
be pursued: 1) Determine if amplification modifies the odds of suffering a falls-related injury in older adults with
hearing loss. A historical prospective cohort design will be employed that merges existing local audiometric
and hearing aid databases with local electronic medical record data and Medicare data to identify individuals
seeking medical treatment for falls in. Given the potential for residual hearing difficulties in patients with
moderate or greater hearing loss who are amplified with a hearing aid only, a sub-analysis, will be performed to
determine if type of amplification (i.e., hearing aid versus cochlear implant) modifies the odds of a fall-related
injury in this subgroup We hypothesize that those with moderate or greater hearing loss receive greater
auditory benefit from cochlear implantation and therefore, have lower odds of falling. 2) To conduct an
exploratory study of older adults with hearing loss to identify if differences in patient-reported hearing outcomes
(e.g., listening effort, spatial awareness, hearing handicap), patient-reported amplification outcomes, cognitive
and psychosocial factors are associated with falls risk. Validated questionnaires will be used to examine
differences in these domains between fallers and non-fallers stratified by amplification status (user versus non-
user) and type (hearing aid versus cochlear implant). The current proposal is innovative as the work will
determine if hearing intervention influences the risk of falls-injury in older adults and seeks to address the
dose-dependent associations between hearing loss severity and falls. Moreover, it will identify candidate
mechanisms that will further clarify the link between falls and hearing loss. These contributions will be
significant as they will determine if hearing loss may be an appropriate target for intervention to reduce the
societal and healthcare burden of falls and falls-related injury.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE The proposed research is relevant to public health because falls and falls-related injury result in significant morbidity, mortality and disability. The current proposal seeks to determine if hearing intervention impacts the risk of falls-injury in older adults and identify candidate mechanisms that potentially explain the link between falls and hearing loss. This work addresses the NIDCD’s strategic priority area (improving diagnosis, treatment and prevention) and specifically, will determine if hearing loss may be an appropriate target for intervention to reduce the societal and healthcare burden of falls and falls-related injury.